Electrodes for selective stimulation of the lateral spinal cord to restore sensation after lower-limb amputation

PROJECT SUMMARY/ABSTRACT
Advances in design and actuation have led to dramatic improvements in prosthetic limbs. However, these devices cannot
provide sensory feedback, which leads to slow gait and increased risk of falling. Recent evidence from our lab has shown
that stimulation of lateral structures in the spinal cord and dorsal roots can effectively generate sensations in the distal limbs.
In these studies, lateral SCS (LSCS) evoked sensations in regions of the amputated hands or feet, though many of these
sensations also covered more proximal regions of the residual limb. To achieve more focal sensations in the missing limb
will require development of electrodes with smaller contacts, tighter inter-contact spacing, and better arrangements than
currently exist for SCS electrodes. Further, because the lateral epidural space is narrower and more curved than the
traditional midline target of SCS, these novel SCS electrodes must be thinner and more flexible than existing SCS devices.
Our long-term goal is to create a neurostimulation system to restore sensation by selectively stimulating lateral
structures in the spinal cord. In this project, we will characterize how the DR respond to LSCS and optimize
electrode design for stimulating these structures. Through a combination of large animal neurophysiology experiments,
histological analyses, and computational modeling studies, we will characterize the selectivity of LSCS and design
electrodes to maximize selectivity and achieve focal paresthetic coverage of the foot and ankle while avoiding injury to the
underlying neural tissue. To achieve these goals, we will complete the following aims:
Aim 1: Quantify functional organization of the lumbar DR and selectivity of LSCS.
We will measure the selectivity of LSCS in cats by recording antidromic propagation of evoked action potentials in
nerves throughout the hindlimb. We will also resect the dura and use hook electrodes to repeat these experiments while
selectively stimulating individual DR to characterize their innervation patterns and somatotopic arrangement.
Aim 2: Develop an anatomically-accurate computational model of the spinal cord, including the DR, and use that
model as a platform to design LSCS electrodes.
Utilizing high-resolution imaging data and microsurgical measurements of the human spinal cord, we will build a
combined finite element and equivalent circuit model to simulate the anatomy and neurophysiology of lateral structures in
the human spinal cord and their response to LSCS. We will use this platform to design the layout of electrode contacts on
the LSCS device and stimulation configurations and waveforms to maximize selectivity of stimulation of individual DR.
Aim 3: Perform large animal surgeries to optimize the mechanical properties of the LSCS electrode substrate to
avoid neural damage and maintain chronic stability of electrode placement.
In pigs, we will chronically implant LSCS electrodes with multiple different mechanical substrate designs, including
varying the cross-section of the device and any tooling that may aide in insertion and stabilization of the device. We will
perform histological analysis to characterize tissue damage and the relationship between mechanical properties and tissue
injury.

Public health relevance
PROJECT NARRATIVE The impaired sensory function that results from lower-limb amputation often causes reduced balance control and an increased risk of falling. Electrical stimulation of the lateral spinal cord in the low back can produce sensations that feel like they come from the missing limb, although currently available electrodes often produce sensations that cover large regions of the missing foot and residual limb. In this project, we will perform large animal experiments and computational modelling studies to develop new electrodes for lateral spinal cord stimulation and we will chronically implant these devices near the spinal cord in pigs to measure their stability and safety over time.